Pediatric Heart Network (PHN) - Utah Center

PROJECT SUMMARY/ABSTRACT
Utah has been one of the most productive Core Clinical Research Centers in the Pediatric Heart Network
(PHN) since its inception in 2001 and has supported the mission to improve health outcomes for individuals
with congenital (CHD) and pediatric acquired heart disease, disseminate collaborative findings, train and
educate new investigators, and provide support and advocacy for families during the conduct of excellent,
ethical clinical research. During the current funding cycle, PHN Utah implemented a leadership transition plan
with the next generation of locally and PHN trained researchers joining senior investigators with >20 years of
PHN experience. They led 6 studies and made substantial contributions to PHN scientific discoveries and
administrative activities. Recruitment and retention of participants was among the highest of all centers due to
the committed, diverse PHN Utah team with 24-hour coverage to approach every eligible patient. The long-
standing collaborations among Utah investigators, planned leadership transition, and continued strong
institutional support will allow a seamless transition into the next cycle. Going forward, the increasing diversity
of the Intermountain West will provide unique access to participants unrepresented in research: rural and
frontier populations, Native American/Alaska Native, and Native Hawaiian/Pacific Islander communities. PHN
Utah is ideally positioned to contribute to a more equitable, diverse, and inclusive PHN focused on addressing
health care inequities and the 2 specific pillars to support transformational impact: 1) addressing existing
inequity in clinical outcomes and 2) big data/data science using existing infrastructure. PHN Utah will expand
their successful collaboration with Utah’s Pediatric Cardiac Genomics Consortium to develop a robust
mechanism for extracting and sharing pertinent, machine-readable clinical data from Electronic Health Records
across all PHN sites and use a robust Artificial Intelligence platform to explore the complex interplay between
phenotype; genotype; maternal, clinical, social determinants of health (SDOH), and racial/ethnic factors; and
clinical outcomes. Our aims are to 1) enhance PHN Utah’s exemplary performance and leadership by building
on prior experience with a new vision and additional expertise and infrastructure informed by lessons learned
from PHN leadership roles, collaborations, and studies, 2) address EDI issues in all aspects of research and
training to amplify successes in mentoring the next generation of researchers in an increasingly diverse and
inclusive research environment, and 3) create the PHN Data Resource consisting of clinical, genomic, and
SDOH data to empower equitable, personalized outcomes prediction. PHN Utah is committed to the overall
mission of the PHN, has a proven track record of contributions to the success of the PHN, effective leadership
locally and within the PHN, strong institutional support, proven mentorship of the next generation of physician
scientists, and will add significant resources to address equity and diversity, and provide existing infrastructure
to support a big data approach to personalized medicine.

Public health relevance
PROJECT NARRATIVE As a Core Clinical Research Center for >20 years, Pediatric Heart Network (PHN) Utah has supported the mission to improve outcomes for individuals with congenital heart disease and pediatric acquired heart disease, and made particularly exceptional contributions to scientific discoveries, administrative activities, and training the next generation of researchers. Going forward, PHN Utah will bring participants from unique underrepresented groups as well as additional resources and expertise to address inequities in all aspects of research with the infrastructure and experience to lead a big data approach to collecting clinical, genomic, and social determinants of health data to empower equitable personalized outcome prediction. Based on its history of excellence, well defined leadership transition plan, and unique research infrastructure, PHN Utah is ideally poised to seamlessly move into the next cycle and increase their considerable contributions as a Clinical Research Center.